Path C AZDA- Produce Safety Rule Program

Arizona Department of Agriculture Project Summary
This Arizona Department of Agriculture (AZDA) project entitled Arizona Produce Safety Rule
Implementation, is intended to facilitate long-term improvement to the national food safety
system. The overall purpose of the Funding Opportunity Announcement (FOA): PAR-21-174 is
to advance the efforts for a nationally integrated food safety system (IFSS) by supporting state
and territory food safety programs to enhance produce safety and achieve high rates of
compliance with the FDA's Produce Safety Rule by way of regulatory programs focused on
quality and national consistency. Furthermore, data gathered through the Produce Safety Rule
Cooperative Agreement will provide the FDA with additional and accurate information on
production that will ensure better management of the Produce Safety Rule (PSR), in addition to
providing better outreach to those that will have to comply with the regulatory mandates.
Through the previous funding opportunity, the Arizona Department of Agriculture (AZDA)
received its PSR inspection authority (A.R.S. § 3-525.04 -
https://www.azleg.gov/arsDetail/?title=3) and then developed Administrative Rules
(https://apps.azsos.gov/public_services/Title_03/3-10.pdf) which adopted the Produce Safety
Rule, allowing staff to conduct produce safety inspections under our own authority.
The overarching goal of the program is to protect public health through the safe production of
fresh fruits and vegetables. Minimizing the risks of pathogen contamination is key to preventing
foodborne illnesses. As we strive to meet the goals in each of the 7 objectives, we are confident
that we will achieve the overarching goal of the PSR. We will continue to leverage existing
expertise, knowledge and resources in our state to provide education, training, and technical
assistance to all produce farms.

Public health relevance
Arizona Project Narrative This Arizona Department of Agriculture (AZDA) project entitled Arizona Produce Safety Rule Implementation, is intended to facilitate long-term improvement to the national food safety system. The AZDA project intends to further the development of an integrated fresh produce food safety system in Arizona. This will be done through training/outreach and inspection/enforcement of the United States Food and Drug Administration (FDA) Food Safety Modernization Act (FSMA) Produce Safety Rule.